The Role of miR-219a-5p in Bone Metabolism

PROJECT SUMMARY/ABSTRACT
Osteoporosis is a common clinical condition characterized by low bone mass that increases the risk of fragility
fractures in the elderly population. Since bone formation is clearly impaired in osteoporotic patients, a more
complete understanding of the fundamental molecular mechanisms that regulate bone metabolism is likely to
lead to the development of novel therapies. Therefore, identification of novel molecular pathways which
influence bone formation is crucial to the development of clinical treatments to combat osteoporosis. Our
previous work has definitively established that the anti-osteogenic transcription factor, retinoic acid receptor-
related orphan receptor-beta (Rorβ) plays an inhibitory role in osteoblast differentiation. Increasing expression
levels of Rorβ during physiological aging contributes to bone loss, as mice lacking Rorβ exhibit higher bone
mass through activation of the bone anabolic Wnt pathway. This leads to the notion that inhibition of Rorβ may
represent a novel paradigm to increase bone mass throughout the aging process. We hypothesized that
microRNAs (miRs) may control Rorβ levels, and found that a specific miR, miR-219a-5p (miR-219a), the top
predicted Rorβ-regulatory miR, exhibits an inverse expression pattern to Rorβ, suggesting a potential
Rorβ/miR-219a regulatory axis in bone. We demonstrate that miR-219a directly regulates Rorβ levels in
osteoblasts, that delivery of miR-219a mimics enhances osteoblast differentiation, and that miR-219a
antagonists suppress differentiation. We further show that miR-219a increases the activity of the bone anabolic
Wnt pathway. Therefore, we propose that miR-219a is bone anabolic and may be used to preserve bone mass
with age, possibly through increasing Wnt pathway activity. Using a novel mouse model where we can activate
miR-219a expression in a tissue-specific manner, in Aim 1 we will determine the effects of miR-219a in Rorβ-
expressing cells on adult bone mass or following a fracture, with the hypothesis that downregulation of Rorβ
through miR-219a will increase bone mass and accelerate fracture healing. In Aim 2, we will explore the more
general effects of miR-219a in bone homeostasis by activating miR-219a in various bone cell lineages, with the
hypothesis that downregulation of Rorβ, and/or other miR-219a targets in these lineages, will increase bone
mass with age. Finally, in Aim 3 we will perform in vitro experiments to explore the molecular mechanism of
how miR-219a regulates the Wnt pathway and determine whether direct targeting of Rorβ by miR-219a affects
Wnt activity and bone cell function. Completion of these pivotal studies will not only provide a more complete
understanding of miR-219a function in bone, but if positive will also provide a strong justification for pursuing
miR-219a mimics as a novel therapeutic strategy to stimulate bone formation in various clinical conditions.

Public health relevance
PROJECT NARRATIVE This project will advance understanding of the biological mechanisms by which the specific microRNA, miR- 219a-5p, functions as a novel anabolic (e.g. bone forming) agent in bone metabolism. This knowledge could potentially lead to novel clinical treatments using miR-219a-5p mimics as a molecular tool to enhance bone formation in vivo, during both aging or following a fracture.